Early Onset Diastolic Dysfunction in HCM: Identifying New Mechanisms and Targets

Summary
Mutations in genes that encode the proteins of the cardiac sarcomere are a primary cause of
hypertrophic cardiomyopathy (HCM). HCM represents the most common genetic cardiac
disorder and is characterized by a complex and progressive clinical course exhibiting broad
phenotypic variability and, for patients carrying mutations in sarcomeric genes in particular,
significant morbidity and mortality. Recent longitudinal studies have begun to define the natural
history of HCM and revealed a “preclinical” stage in genotype-positive cohorts. Before the
availability of genetic testing the majority of patients presented with significant symptoms and
late stage cardiac remodeling, thus limiting their response to treatment. The ability to identify
patients before the onset of irreversible HCM opens a therapeutic window whereby genotype-
positive, phenotype-negative patients can be treated before the onset of pathogenic remodeling
and thus perhaps change the natural history of this lifelong disorder. This goal will require the
ability to precisely identify primary disease mechanisms at the level of the complex and dynamic
cardiac sarcomere. An enduring clinical challenge in HCM remains the treatment of patients
with diastolic dysfunction (impaired left ventricular relaxation) which manifests as shortness of
breath, often with minimal exertion and is one of the most common manifestations in this
otherwise diverse disorder, thus representing a significant unmet need. To date, our group has
focused on mutations in the regulatory thin filament and developed a program that combines
structural biophysics with in vitro experiment, in vivo animal models and an experimentally
validated all-atom computational model of the cardiac thin filament (cTF). As the thin filament is
the primary arbiter of cardiac relaxation at the molecular level we now propose to apply our
integrated approach to first, in Aim 1, fully characterize (at the atomic level) three specific
functional domains of the cTF linked to the regulation of relaxation, determine the mechanistic
effects of known cTnT mutations on these domains and second, in Aim 2 use this information to
design Fluorescence-based High Throughput Screens to identify, validate and test in vivo (via
existing cTnT and MyHC– linked HCM mice) novel small molecule modulators of diastolic
performance. Successful completion of these studies will not only provide new knowledge
regarding thin filament function and regulation, it will also provide a proof of principal approach
to the targeting of the cardiac thin filament that can be applied to other sarcomeric disorders.

Public health relevance
Narrative: This proposal focuses on the pathogenesis of hypertrophic cardiomyopathies caused by mutations in the cardiac sarcomere. These are complex disorders and recent clinical studies suggest that early treatment may significantly improve patient outcome. We thus propose to use our combined computational and biophysical program coupled to our mouse models of genetic hypertrophic cardiomyopathy to discover new myofilament- based disease mechanisms that will help us develop screens for novel candidate small molecules and test these putative drugs on our mouse models.